Functional characterization of viral-bacterial-human interactions during antimicrobial and inflammatory perturbations across different lifespans

ABSTRACT
The gut microbiome (GM) strongly influences human health, playing critical roles in immune priming, nutrient
metabolism, and pathogen exclusion. During infant and child development, the GM undergoes a systematic
turnover of species until reaching an adult-like state. The equilibrium of the gut ecosystem can be disrupted by
perturbations, such as antibiotic usage and inflammatory exposures, causing significant decreases in microbial
diversity and aberrant physiological processes, sometimes with lifelong implications. However, the mechanisms
underlying the resilience of the GM to shifts or perturbations are not well understood. The gut virome is dominated
by bacteriophages (phages), which play crucial roles in shaping bacterial communities through predation and
horizontal gene transfer. Viruses can also directly interact with human cells to influence gut physiology. Herein,
we hypothesize that altered viral communities are both symptoms of and contributors to human disease, as
gastrointestinal perturbations drive phage induction and subsequent virus-bacteria and virus-human interactions
which impact human health. Accordingly, we propose to study virus-bacteria-human dynamics during antibiotic
exposure and inflammatory diseases, leveraging over 70,000 banked patient stools from four cohorts with well-
curated clinical metadata. The rationale implicating a functional role for viruses in human gut health is that
changes in the abundance of specific viruses targeting certain bacterial populations are frequently observed in
perturbed GM states. These include antibiotic exposure and intestinal inflammatory conditions for which there is
no clear bacterial etiological agent, such as inflammatory bowel disease in adults and necrotizing enterocolitis
in preterm infants. Our central motivation is to provide a comprehensive analysis of human gut ecology during
dramatic GM shift events that are consistently correlated with virome alterations. Understanding these alterations
is critical for the design of virus-related diagnostic or therapeutic strategies to improve inflammatory disease
outcomes and antibiotic-triggered GM imbalance. This will be achieved through two aims to: I) Define the
interactions between viruses, bacteria, and human cells contributing to perturbation-associated shift events, and
II) Determine the effects of host-associated perturbations on gut viruses and their contributions to the
inflammatory responses in mammalian cells and GM-humanized mouse models. Our analyses are significant as
they provide a systematic investigation of the relationship between GM perturbations and virome alterations in
adult and pediatric populations. Our proposal is innovative in leveraging novel complementary technologies
including high-resolution genomics, viral tagging of bacterial and human cells, and GM-humanized gnotobiotic
mouse models to identify viral drivers of clinical outcomes. Our proposal is impactful in its goal to address basic,
translational, and clinically relevant questions in functional virus-bacterial-human interactions related to human
health and disease.

Public health relevance
PROJECT NARRATIVE Significant shifts in the gut microbiome are observed when humans are exposed to antibiotics or during gut inflammatory conditions, yet the causes and functional consequences of these shift events on human health, including the contributions of the gut virome, are poorly understood. The proposed study addresses this knowledge gap by leveraging an extensive collection of stools and associated clinical data from healthy or perturbed infants and adults to i) characterize the viruses associated with microbiome shift events and their bacterial hosts, ii) determine the in vitro and in vivo effects of antibiotics and inflammation on viral activities, and iii) define the immunological causes and effects of altered viromes on the mammalian host. By directly investigating viral-bacterial and viral-eukaryotic relationships, this project supports the goal of functionally characterizing the human virome to understand its role in human health and disease.